Flow Cytometry

2009-2010 Flow Cytometry Core Utilization Report PI - Fellow (or staff/student) using the Core. Each may have multiple projects Adelstein - Kim Adelstein Wang Balaban - Reilly Barrett - Melenhorst Beaven - Andrade Boehm Kovacic Boehm - Lee Boehm - Ma Boehm Chen Boehm St Claire Burg Gallazzini Burg - Williams Childs - Betters Childs - Berg Childs - Lopez Childs - Lundqvist Childs - Ramanathan Childs - Su Childs Vasu Chock Zhao Donaldson Eyster Donaldson Shliom Dunbar Baresse Dunbar Larochelle Dunbar Xie Dunbar - Metais Finkel - Kawai Finkel - Liu Finkel - Quijano Greene - Zhao Hwang - Lago Hwang - Wang Hwang -Sung Kato Wood Knepper Chou Knepper - Yu Kotin Li Kruth Anzinger Kruth - Leyva Leonard Liao Leonard - Wan Levine - Yao Levine - Yu McCoy - Dagur Michelson - Busser Michelson Kim Michelson - Zhu Mitchel - Washington Mohiuddin - Singh Moss - Kato Moss - Cai Moss - Steagall Moss - El-Chemaley Moss - Pacheco Mukoyama Hu Mukoyama ODonnell Mukoyama Li Mukoyama - Uchida Nirenberg - Rovescalli Nirenberg - Ivanov Pohl - Chakraborty Pohl Masson Puertallano - Vergarajauregui Restifo - Hinrichs Sack - Bao Sack - Kim Sack - Scott Sack Stevens Sack - Lu Sloand - Tucker Solomon - Chen Song - Herndon Tisdale/Remaley - Washington Waterman - Pasapera Waterman Thievessen Waterman - Plotnikov Wiestner Vire Wiestner - Aue Young - Erie Young - Chen Young - Feng Young - Calado Zhao - Northrup